INCREASING WELL BEING IN AFRICAN AMERICAN WORKING WOMEN

DESCRIPTION (As Adapted from the Investigator's Abstract): The primary purpose of this program of research is to determine the effectiveness of a six-session psychoeducational intervention in reducing the role conflict and depression and increasing instrumentality, self-esteem and life satisfaction among African American blue collar working women. The secondary purposes are to (a) understand the lived experience of role conflict among African-American working women and (b) refine the psychoeducational intervention in preparation for additional testing among African American working women. The short term desired outcome is to reduce role conflict and increase instrumentality. The longer-term outcome is to decrease depression and increase life satisfaction and self-esteem six months post intervention. A triangulated method, combining both qualitative and quantitative methods, will be used. The quantitative portion of the study will be based on a pretest-posttest control group design and random assignment to one of two treatment conditions. The hypotheses will be addressed using univariate and multivariate assessment of scores from standardized instruments and sociodemographic data. The six one-and-one-half hour interventions will occur weekly over a six-week period, one intervention per week, and will be delivered to three groups, each with 14 participants. Intervention content includes coping, self-esteem, assertiveness and role conflict. Intervention strategies include presentation, discussion, and handouts. Group social support is expected to play a role in outcome achievement and will be measured. Three groups, each with 14 participants will serve as controls, meeting twice, once during week one and once during week six. Members of the control group will be given a general (placebo) intervention consisting of information on nutrition and exercise. This effectiveness trial of an intervention will be conducted under real-world conditions. Group meetings will be held at various worksites.